The Alzheimer's Disease Translational Data Science Training Program

PROJECT SUMMARY/ABSTRACT (DESCRIPTION)
The Case Western Reserve University (CWRU) Alzheimer’s Disease Translational Data Science (ADTDS)
Training Program is designed to power therapeutic discovery by producing a new generation of scientists cross-
trained in clinical research of Alzheimer’s Disease (AD) and analysis of large scale ‘omics data. Focused on
predoctoral PhD and MD PhD students, this training program fills a critical gap between these disciplines in
academic graduate programs. The ADTDS builds upon the Cleveland Alzheimer’s Disease Research Center
(CADRC), and multiple ongoing national collaborations responsible for generating large-scale multi-omic data
on diverse populations with AD. As part of this training program, trainees will: 1) Form multi-disciplinary
mentorship teams to expand understanding of AD etiology and disease course through data analysis, 2) Interact
with a variety of faculty who are world-recognized leaders in AD genetics, pathology, and neuroscience, 3)
Access large-scale data from national initiatives supported by NIA, including the ADSP, ADGC, ADNI, and AMP-
AD, to answer translational and basic research questions, and 4) Receive specialized training in responsible
conduct and research reproducibility with special considerations for data science. Our cross-disciplinary training
program provides strong mentoring and uses state-of-the-art data science experiences within the rich
environment of the CWRU School of Medicine and its affiliated hospital systems to develop independent
investigators who will lead the next generation of translational research in Alzheimer’s Disease.

Public health relevance
PROJECT NARRATIVE The Case Western Reserve Alzheimer’s Disease Translational Data Science (ADTDS) Training Program cross- trains pre-doctoral students in data science and translational research techniques to become productive, independent scientists focused on Alzheimer’s Disease treatment therapeutic discovery. Our trainees are selected from a competitive pool of Ph.D. applicants, and develop research projects within a rich collection of National Institute on Aging funded programs with nationally and internationally recognized leaders in AD research.